FASEB SRC: The Protein Phosphatases Conference

ABSTRACT
This application requests support for the 2022 edition of the Federation of American Societies for Experimental
Biology (FASEB) Summer Research Conference on Protein Phosphatases. This conference will be the 16th
edition of a recurring series of bi-annual meetings, the sole meeting in North America on this topic held
continuously since 1990. Its 2020 edition had been awarded funding from NCI through R13 CA247237
(scored 26) but unfortunately the conference had to be cancelled because of the COVID-19 pandemic and the
grant was returned to the NCI. We are planning now to re-organize it in 2022 as the first merger between
the two longest-standing world phosphatase conferences: the FASEB protein phosphatase and the
Japanese Association for Protein Phosphatase Research (JAPPR) Conference (at its 15th edition in 2022). The
conference will provide an intense yet collegial environment for researchers to discuss and explore cutting-edge
areas of current research on protein phosphatases and their roles in cellular biology and human pathology. The
2022 conference aims to 1) present the most current work on the structure, regulation and function of the protein
phosphatases with particular attention to their roles in human disease; 2) highlight major achievements and new
approaches, generate conduits to integrate them with other fields of research, and fuel interest in phosphatases
as drug targets; and 3) to renew and refresh the community of phosphatase researchers engaging new and
junior scientists and facilitating ties and collaboration between the FASEB and JAPPR phosphatase research
communities. To achieve this, the 2022 conference is designed to cover the whole range of phosphatase science
from basic to translational. Several scientific sessions are focused on the biochemistry and cell biology of some
of the more than 1000 forms of these complex enzymes. Sessions dedicated to the role of protein phosphatases
in diverse systems and organs—e.g. the nervous and immune systems- provide ideal platforms for cross-
discussion of findings in normal vs pathological tissues and organs. Cancer will be a cross-cutting theme of the
conference and will also be especially featured in two sessions and in the keynote lectures. Recent novel
approaches have been progressively improving druggability of phosphatases, with multiple agents now in
advanced clinical trials. Thus, another cross-cutting theme will be therapeutic targeting of phosphatases.
Speakers will include experts from academia and industry, and talks on late-breaking advances and short talks
selected from submitted abstracts will be given by new investigators, graduate students, post-doctoral fellows,
and those from outside the field with a goal of increasing representation by women and minority scientists. The
Omni Resort in Palm Springs provides a secluded venue that fosters informal interaction, discussion, and
collaboration between the expected 150 participants. Altogether, the impact of the 2022 FASEB Conference on
Protein Phosphatases will be to augment our understanding of fundamental protein phosphatase biology and
pave the way for development of new therapies targeting phosphatases to improve human health.

Public health relevance
NARRATIVE Protein phosphorylation -mediated by protein kinases and phosphatases- is fundamental to life and its discovery was the object of a Nobel prize in 1992. Protein phosphatases are critical players in most cellular processes and phosphatase dysregulation contributes to the pathogenesis of human diseases such as cancer, metabolic syndromes, and cardiovascular, neurological and immune disease. This American-Japanese jointly organized conference is the first merger between the two longest-standing world phosphatase conferences and will serve as a major international platform for researchers who are focused on studying protein phosphatases to present and discuss current cutting-edge advances.